Allosteric control of collagen fibril degradation by matrix metalloprotease-1

Project Summary
Collagen, the most abundant human protein, provides a scaffold for cells to maintain tissue and organ integrity.
Fibrillar collagen is highly resistant to proteolysis and is degraded by specific matrix metalloproteases (MMPs).
The degradation of fibrillar collagen is an essential part of tissue remodeling and is involved in many normal and
pathological processes. While the degradation of triple-helical collagen monomers is well-studied, degradation
of native collagen fibrils remains poorly understood. Fibrils are insoluble in physiological buffers, heterogeneous,
and extended substrates, making them challenging to study using standard biochemical assays. We have
overcome these limitations by developing a single-molecule method to track and analyze the motion of labeled
MMPs on fibrils using a home-built total internal reflection fluorescence microscope (TIRFM). We propose to
study the roles of MMP1 and MMP9 in degrading type-1 collagen fibrils. MMP1 can degrade triple-helical
collagen, whereas MMP9 cannot degrade triple-helical collagen significantly. However, MMP9 is upregulated in
numerous skin diseases, cancer metastasis, wound, inflammation, pneumonia, and atherosclerosis. We propose
to study the mechanism of fibril degradation by two important MMPs by a combination of single-molecule
tracking, innovative analysis, simulations, ensemble assays, and animal studies.

Public health relevance
Public Health Relevance Statement This project will investigate the mechanism of collagen fibril degradation by matrix metalloproteases (MMPs). Collagen degradation plays an essential role in tissue remodeling and cell invasion and underlies many diseases, including numerous skin diseases, cancer metastasis, wound, inflammation, pneumonia, and atherosclerosis. Understanding the mechanism of degradation can significantly impact public health by identifying better therapeutic targets and strategies.